Evaluating the impact of academic tracking and de-tracking on substance use and health during adolescence and the transition to adulthood

Academic tracking is a widely used practice that groups students into classes according to prior academic performance. In addition to potential long-term impacts on education attainment, academic tracking may directly affect adolescent social networks and substance use behaviors. By grouping students together with similarly performing peers, tracking may reinforce school disengagement and risky health behaviors like substance use, violence, and delinquency among lower-performing students. However, no known studies examine the health implications of academic tracking nor tested whether interventions to modify tracking positively impact health. Advancement via Individual Determination (AVID) is a successful college preparatory program that works in part by “de-tracking” students. AVID targets students in the academic middle (typically B- and C-average students) who are not typically placed in high-achieving academic tracks and places them in rigorous college-preparatory courses, while providing them with academic support to ensure their success. In our pilot study, a handful of students within 5 public high schools were randomized to AVID. We found the program led to connections with more pro-social peers and lower odds of substance use and delinquency. When applied school-wide, AVID trains schools to ensure all students have access to rigorous college-preparatory courses. However, there are no studies testing the health effects of AVID’s school-wide program. We propose a longitudinal study of adolescents attending schools with widespread AVID implementation and matched comparison (low or no AVID implementation) schools (matched on location and student characteristics) from communities in Southern California. Participants will be followed for 4 years to test whether exposure to AVID leads to a) lower rates of 30-day substance use (primary outcome--defined as any alcohol, tobacco, vaping, cannabis, prescription, or illicit drug use in the prior 30 days), and other substance use behaviors, violence and delinquency; b) increased enrollment in college-preparatory course taking and healthier social networks (measured by fewer peers engaged in substance use, more peers engaged in school, and more school-related adults); and c) whether associations between AVID and substance use are explained by increased college-preparatory course taking and healthier social networks. We will follow 9th-12th grade students at intervention and control schools for 4 years, collecting administrative education data and health behavior and social network survey data as they progress through high school and transition to college and/or the work force. This study will yield critical knowledge that can inform education and health policy regarding academic tracking and the use of de-tracking interventions like AVID. This topic is in keeping with NIDA’s mission to develop and disseminate research that significantly improves drug abuse and addiction prevention.

Public health relevance
This study is relevant to public health in that it will test whether an intervention to reduce academic tracking reduces substance use and other risky health behaviors during adolescence and the transition to adulthood. Adolescent substance use may have long-term impacts on brain development, in addition to associations with other risky health behaviors and future substance abuse disorders during the transition to adulthood. Academic tracking may directly affect adolescent and young adult social networks, substance use, other health behaviors, and long-term health and life trajectories.